Leveraging machine learning for cardiovascular disease risk prediction and prevention in women with a history of adverse pregnancy outcomes

PROJECT ABSTRACT
Each year, more than a million US women experience adverse pregnancy outcomes (APOs) associated with a
two-fold higher risk of future maternal CVD. These APOs include preeclampsia, gestational hypertension,
gestational diabetes, preterm delivery (<37 weeks), and delivery of a small for gestational age infant. The
American Heart Association and American College of Cardiology recognize APOs as risk factors for CVD.
However, it is not yet known how to identify which women with a history of an APO are most at risk; nor are
specific, modifiable CVD risk factor trajectories from each APO to CVD well described. To date, risk prediction
exercises have only examined the utility of adding individual APOs to existing CVD risk scores. No risk
prediction exercises have addressed the clinically relevant question of which women with APOs are most at
risk for CVD, and no clinical decision support tool exists to direct care after an APO.
We propose to develop a risk classification approach to identify maternal risk phenotypes at the time of
delivery of a pregnancy complicated by an APO that are predictive of future CVD risk factors and events.
Predictive factors that inform these phenotypes may include history of individual APOs or combinations of
APOs, delivery complications, infant outcomes, and maternal demographic or behavioral factors available at or
shortly after delivery (e.g., preterm preeclampsia with BMI <30 kg/m2). We will use machine learning to
elucidate novel maternal CVD risk phenotypes in several populations: two longitudinal Nurses’ Health Study
cohorts and a retrospective cohort using electronic health record data from the Duke University Health System
and University of North Carolina Healthcare System. A national board of clinical experts will advise the
development of a clinical decision support tool to be tested using mixed methods among panels of
obstetricians, internists, and cardiologists.
Building on the existing evidence connecting APOs to CVD and leveraging the knowledge that CVD prevention
should begin early, this work will create a tailored tool to help clinicians guide the millions of women with an
APO history to appropriate screening, prevention, and referral to reduce their elevated risk of future CVD.

Public health relevance
PROJECT NARRATIVE Women with a history of adverse pregnancy outcomes (APOs) are at increased risk of future cardiovascular disease. The goal of this study is to design a tool to help clinicians identify which women with APOs are most likely to develop CVD and suggest how to help reduce their risk. We will achieve this by: 1) using data from two large, national, longitudinal cohorts as well as a cohort derived from electronic health records of women recently delivering in North Carolina to identify the most common pathways from APO to cardiovascular risk factors to cardiovascular events; 2) engaging clinical experts to design the decision support tool based on the pathways and predicted risks revealed by the statistical analyses; and 3) soliciting feedback from practicing clinicians who would use to tool to help women with a history of APOs to reduce their risk of future cardiovascular disease.